DNA methylation, 3D genome organization and gene expression during Trichomonas vaginalis: host interaction

DNA methylation, 3D genome organization and gene expression during Trichomonas vaginalis: host
interaction
ABSTRACT
Trichomonas vaginalis is a common sexually transmitted parasite that colonizes the human urogenital tract
causing infections that range from asymptomatic to highly inflammatory. Chronic infections can lead to
severe complications such as infertility, premature birth during pregnancy, increases the risk of acquiring
HIV, cervical cancer and aggressive prostate cancer. Hence, understanding how the process of infection in
Trichomonas parasite is regulated remains an important goal in parasitology research and human health.
Host: parasite interaction is regulated by changes in gene expression, but it is still largely unknown how
these changes in transcriptional profiles are controlled as very few transcriptional regulatory elements have
been described. Our recent works highlighted the importance of epigenetics in the regulation of
transcription and possible role in parasite pathogenesis. Specifically, we analyzed the abundance of DNA
methylation demonstrating that N6-methyladenine (6mA), and not 5‐methylcytosine (5mC), is the main DNA
methylation mark in T. vaginalis. Genome-wide distribution of 6mA reveals that this mark is enriched at
intergenic regions, with a preference for certain superfamilies of DNA transposable elements. Interestingly,
bioinformatics analysis revealed the presence of transcriptionally active or repressive intervals flanked by
6mA-enriched regions and results from chromatin conformation capture (3C) experiments suggest these
6mA flanked regions are in close spatial proximity. This finding revealed a new role for 6mA in modulating
3D chromatin structure and gene expression in this parasite. Based on these antecedents we now propose
that 6mA could be a key regulator of 3D genome architecture by modulating expression of transcriptional-
modules of genes during parasite infection. Three-dimensional arrangement of DNA in the nucleus are
increasingly seen as key contributors to the regulation of gene expression but studies on how genome
structure and nuclear organization influence transcription have so far been limited to a handful of model
species. Guided by strong preliminary data, we propose to pursue three specific aims to further analyze the
role of 6mA in the regulation of 3D genome conformation and gene expression during the process of
parasite attachment to host cells. These results will provide new insights into T. vaginalis epigenetic
regulation that may help to understand the mechanisms that lead to parasite adherence and cytotoxicity;
key steps toward dissecting the specific outcomes of Trichomonas infection. Importantly, the association of
6mA with chromatin looping is noteworthy because it points to a novel function for this epigenetic mark in
eukaryotes with scarce 5mC levels.
1

Public health relevance
Trichomoniasis is a sexually transmitted disease (STI) with important public health ramifications; it has been associated with vaginitis, cervicitis, urethritis, and pelvic inflammatory disease. Trichomoniasis also impacts upon birth outcomes, increased susceptibility to HIV infection and cervical cancer in women. Because of increased resistance to treatment and the important health consequences of infection, new research is needed to understand the mechanism the pathogenesis and to identify new drug targets within the parasite. We propose to analyze the role of DNA methylation in the regulation of gene expression and 3D genome architecture to understand how this mechanism contribute to T. vaginalis pathogenesis. The outcome of these studies will provide significant new insights into gene regulation and may lay the foundation for the basis for an attractive new drug targets against Trichomoniasis.